New role of NP Exoribonuclease in Lassa virus infection

PROJECT SUMMARY/ABSTRACT
Mammarenavirus Lassa virus (LASV) causes Lassa fever (LF), which is endemic in West Africa. Vaccines and
treatments for LF are limited. LASV is a Category A Priority Pathogen in the USA and the prototype pathogen in
arenavirus family in the Pandemic Preparedness Plan of NIAID. Despite the significant public health risk posed
by LASV, critical knowledge gaps exist in LASV basic biology. For RNA virus, the RNA synthesis is error-prone
as viral RNA-dependent RNA polymerase (RdRp) lacks proofreading activity. While the high mutation rate of
RNA virus provides evolutionary benefits, RNA fidelity is essential for virus fitness and pathogenicity. For some
RNA viruses, even a moderate increase in mutation rate may substantially affect virus fitness. As a negative-
sense (-) RNA virus, how LASV controls RNA replication error to ensure fitness is unknown. The fidelity of RNA
virus is largely governed by viral RdRp. Interestingly, the preliminary data indicate that LASV utilizes a protein
other than RdRp to reduce nucleotide substitution in LASV RNA, which is arguably the first example in (-) RNA
viruses. Specifically, LASV NP has a DEDDh 3’-5’ exoribonuclease motif (ExoN) that has been known key to
LASV immune suppression via dsRNA degradation. Abrogation of NP ExoN led to increased nucleotide
substitution in LASV genomic RNA, higher sensitivity to mutagenic nucleoside analogues, increased non-
standard viral genomic RNAs (nsVG RNAs) production and impaired LASV RNA replication. Furthermore, serial
passaging of ExoN-deficient LASV led to improved virus titer and RNA level, which was associated with putative
compensatory mutations in RdRp motif G and the Cap-Binding Domain (CBD). The virus passaging data indicate
that LASV NP ExoN and RdRp collaborate to ensure optimal viral RNA replication and fitness. The function of
LASV RdRp motif G and CBD, and more broadly, the function of motif G of (-) RNA virus are largely unknown.
In (+) RNA virus picornavirus RdRp, the ortholog motif G regulates RdRp translocation on viral template RNA
and promotes RNA synthesis efficiency and fidelity. Our working model is that LASV NP ExoN motif has novel
function that ensures viral RNA fidelity, reduces nsVG RNAs production and promotes viral RNA replication
efficiency and fitness. In this project, we will: 1). leverage relevant animal models to investigate the impact of
abrogation of NP ExoN on LASV RNA mutation, nsVG RNAs production and pathogenicity in vivo; 2). investigate
whether the RdRp mutations selected during serial passaging could improve ExoN- rLASV RNA synthesis
efficacy and RNA fidelity; 3) perform biochemical studies to investigate the mechanism underlying the role of NP
ExoN in reducing RNA substitution. This project may define previously unrecognized roles of NP ExoN in LASV
infection in vitro and in vivo and provide insights into the function of LASV RdRp motif G and CBD domain. LASV
NP may be the first example in (-) RNA viruses that a viral protein other than RdRp contributes to RNA fidelity.
Thus, this project may advance our understanding of arenavirus basic biology and move the field forward.
Targeting LASV NP ExoN may be a novel approach for development of LF treatments and vaccines.

Public health relevance
PROJECT NARRATIVE Lassa virus (LASV) from the arenavirus family causes Lassa fever, a disease endemic in West Africa with limited vaccine and antiviral options. LASV nucleoprotein (NP) has a DEDDh 3’-5’ exoribonuclease motif (ExoN) that is important to LASV evasion of innate immunity through dsRNA degradation. This project aims to elucidate novel and important function(s) of NP ExoN in LASV RNA replication, which may advance our understanding of LASV biology and inform the development of treatments and vaccines.